Leveraging Pharmacogenomics in Asthma for Predication, Mechanism and Endotyping

Abstract
Asthma affects over 300 million individuals worldwide. An estimated $81.9 billion dollars were spent on the
diagnosis and management of asthma in the U.S. in 2013. Uncontrolled asthma is associated with a doubling of
direct costs; it has been estimated that 20% of the subjects with asthma contribute 80% of the economic costs of
asthma. For severe asthma, multiple new FDA approved biologic therapies exist, but they remain very expensive
and there are a significant proportion of nonresponders. Current biomarkers may not distinguish reliably between
responders and non-responders; ~40% of those expected to respond continue to have exacerbations and ~40%
of those not expected to respond become symptom free. In this proposal, we will use novel genomics approaches
to assess and predict responses using therapy-induced phenotypes across a spectrum of asthma severity and
endotypes. We hypothesize that comprehensive characterization using clinical metrics, ‘omics’ approaches, and
novel systems biology approaches will generate more precise treatment response biomarkers, further define
disease heterogeneity, and uncover novel biologic mechanisms as related to the therapy of moderate to severe
asthma. To address this hypothesis, we have specified three specific aims, centered around the combination of
a well-characterized, within-person evoked phenotype clinical cohort, including subjects with both type 2 (i.e.
those expected to respond based on current biomarkers) and non-type 2 moderate to severe asthma, to anti-IL5
(benralizumab) and anti-IL4/IL13 (dupilumab) with deep genomic interrogation, including single cell and bulk
RNA sequencing in both sputum and blood across each of the biologic interventions. The first aim will be to
identify, and subsequently validate, pharmacogenomic transcripts that predict response to each therapy, thereby
yielding clinically relevant biomarkers for response to asthma biologics. Our second aim takes advantage of the
biologic interventions as immunomodulators of specific pathways serving as “human knockdown models” to elicit
the underlying mechanistic response at the level of the single cell to the biologic therapies. The final aim will
provide novel insights into cohort via the characterization of genomic signals that influence clinical asthma
subtypes and via the identification of molecular endotypes, which will be compared to the tradtional clinical
subtypes and evaluated for their response to the biologics. Analyses for each aim with include both traditional
statistical models as well as novel systems medicine and network biology approaches. The strengths of our
study include a melding a unique longitudinal clinical evoked phenotype cohort with state of the art genomics
analyses. Successful completion of this study will drive understanding of severe asthma response to biologics
to an unprecendented level, provide novel therapeutic biomarkers leading to direct clinical application, and detail
previously unknown cellular and genomic pathway mechanisms underlying severe asthma.

Public health relevance
Project Narrative Asthma affects an estimated 300 million individuals worldwide, accounts for an estimated $81.9 billion in direct health care costs in the United States annually, with a disproportionate amount directed at more severe asthma. Novel asthma biologic therapies are expensive and there remain a significant proportion of non- responders to those therapies. Through a clinical cohort characterizing within-person genomic responses, this proposal has the potential to personalize asthma therapeutic response to these biologic agents and provide detailed understanding about the mechanisms underlying asthma that may one day be relevant to the further treatment or prevention of this disease.